Role of Autophagy in Type 2 Diabetes Microvascular Dysfunction

Project Summary
This K99/R00 application proposes a comprehensive career development plan and a series of investigations,
coupled with an outstanding mentoring committee specifically tailored to assist completion of postdoctoral
training and establish an independent research program. This proposal is multi-faceted, leveraging previous
training in human subjects research to complement current postdoctoral training to investigate the fundamental
mechanisms underlying microvascular dysfunction in Type 2 Diabetes Mellitus (T2DM). Autophagic flux is
necessary to maintain a healthy microvascular environment. T2DM is associated with reductions in autophagic
flux, however whether this underlies the rampant microvascular defects associated with the disease is unclear.
During the K99 phase we will examine whether T2DM is associated with a pathological switch in the mechanism
of microvascular vasodilation to shear stress in isolated arterioles, and examine whether autophagic flux
contributes to cutaneous microvascular function in T2DM using laser Doppler flux coupled with microdialysis. Dr.
Hughes will train under the mentorship of a transdisciplinary group of senior scientists with research expertise in
mechanisms of microvascular dysfunction, and examination of cutaneous microvascular function within the
context of T2DM. The current postdoctoral mentors, Drs. David Gutterman and Andreas Beyer, both of whom
have extensive experience mentoring trainees will continue to serve as mentors. They will be complemented by
mentoring expertise from Naomi Hamburg and Lacy Alexander. The primary goal is to become an expert in the
field of human microvascular physiology within the context of T2DM. This will be achieved through 1) expansion
of technical skills including molecular techniques, along with laser Doppler flowmetry coupled with microdialysis;
and 2) empirical training in lab and clinical trial management, along with team science and mentoring skills.
Achieving these goals will strengthen further scholarly activities, establish important collaborations, and acquire
critical data that will ensure a successful transition to independence. The training plan will be strengthened
through a sabbatical in the laboratory of Dr. Lacy Alexander, where Dr. Hughes will be trained in investigation of
microvascular function in the human cutaneous microvasculature. Obtaining an independent educational
experience in one of the world’s most successful laboratories that utilize this technique will strengthen the ability
to conduct translational studies. Collectively, this team will provide an outstanding training environment that will
fill critical gaps in knowledge and skill set relating to the mechanisms contributing to microvascular dysfunction
in T2DM. For the transition to independence phase, the mechanistic contribution of Transcription Factor EB
(TFEB), a master regulator of lysosome biogenesis, will be investigated utilizing the skills and techniques learned
and mastered during the K99 phase. The components of this application are consistent with the career goals of
becoming an independent investigator whose research intersects basic and clinical science.

Public health relevance
Type 2 diabetes mellitus (T2DM) is an independent risk factor for future cardiovascular events, often preceded by microvascular endothelial dysfunction. Endothelial function has been demonstrated to be regulated by autophagy, but there is little understanding of the mechanistic role of autophagy within the T2DM microvasculature. The overall goal of this application is to determine the fundamental mechanisms contributing to microvascular dysfunction in T2DM, we hypothesize that impaired autophagic flux mechanistically contributes to microvascular dysfunction through alterations in Transcription Factor EB in T2DM.